Administrative Core

ADMINISTRATIVE CORE PROJECT SUMMARY/ABSTRACT
The general goals of this application for a new P30 ADRC at Columbia University include creating an
infrastructure for research on AD and related disorders, fostering interdisciplinary collaborations across many
departments, providing a rich training environment, and supporting outreach and patient recruitment. More
globally, the goals of our Center will extend to include participation in national coordinating efforts, working with
the national network of AD centers, and working with the National Institute on Aging and other organizations in
their advocacy efforts. Embedded within the general goals, the Center’s thematic goal will be on better
understanding the three biological pathways now considered to act as pathogenic drivers in AD: An ‘immune
response’ pathway, a ‘cholesterol metabolism’ pathway, and an ‘endosomal trafficking’ pathway. Both the
general and thematic goals were conceived with NAPA’s ambitious milestones in mind-- to prevent or treat AD
and related disorders, to optimize patient care, to extend patient support, and to enhance public awareness.
The Administrative Core will act as the executive governing body of the Center that, with the guidance of its
various committees, will provide the vision and leadership necessary to achieve the Center’s general and
thematic goals. The Core will implement this vision by exercising managerial oversight over all aspects of the
Center, which includes assuring the highest standards of scientific and bioethical conduct, and a judicious use
of resources and funds.
More specifically, the Core will achieve its goals by: Directing regular meeting with the Center’s Core leaders
and administrators; working with an external and internal advisory committee; assuring delivery of data and
biospecimens to investigators and to national consortia; and assuring and enhancing the Center’s community
outreach and research education mission.